A Paper-Based Synthetic Biology Platform for the On-Demand Testing of Water Quality

PROJECT SUMMARY/ABSTRACT
Safe drinking water is essential for public health yet is increasingly threatened by anthropogenic activities and
aging infrastructure that contaminate it with heavy metals and other toxins. Most notable in the United States is
the contamination of drinking water with lead, a heavy metal that is pervasive in America’s water infrastructure
and indoor plumbing. Chronic exposure to lead results in numerous adverse health and societal outcomes and
is an environmental injustice that widens inequalities. Upon discovery, lead contamination can be mitigated by
changing drinking water source, flushing, and existing filtration technologies. However, as recent events such
as the crises in Flint, MI or Newark, NJ exemplify, improper management can lead to major public health threats
by creating community-wide exposure to dangerously high levels of lead. Lead contamination of drinking water
is widespread across the United States due to aged infrastructure and domestic plumbing that heavily relied on
lead. Frequent monitoring for the presence of lead contamination in drinking water is part of the solution. It can
identify where problems exist, alert consumers without delay, and inform risk mitigation and remediation
strategies. However, reliable testing remains limited to analytical chemistry techniques that are costly, time
consuming, and require substantial laboratory infrastructure and technical expertise. This complicates the large-
scale of testing needed to address the lead in drinking water crisis and is a barrier to the routine testing of water
supplies by consumers. Here, we propose to address these issues by pursuing the next stage of development
of our technology platform that will allow for the reliable, inexpensive, on-site, and on-demand monitoring of lead
in drinking water. Our technology is built from recent innovations in synthetic biology that allow us to repurpose
biological sensor proteins that detect specific toxic ligands, such as heavy metals, into ‘cell-free’ reactions that
produce detectable signals when lead is present. These biochemical reactions are
safe and can be embedded
on paper devices for long term storage and distribution. Adding water to these paper-based devices activates
the biochemical reaction and produces a visual signal in the presence of a toxic compound. This Phase II
proposal details a series of complementary aims for achieving improved specificity and sensitivity of this lead
testing device, using a human-centered design process to improve test operation and results interpretation, and
adapting our manufacturing and quality assurance/quality control processes for a scale-up of manufacturing
capability for validation studies. A successful outcome of this proposal will lead to a rapid lead test with sensitivity
comparable to laboratory testing, an accessible and easy-to-use device format with a companion mobile app,
and pilot-scale production to validate our lead sensing technology in the laboratory and in the field. This work
will enable manufacturing and commercial distribution of a highly sensitive and rapid lead biosensor, which will
help address the growing water quality crisis in the United States and beyond.

Public health relevance
PROJECT NARRATIVE Clean drinking water—free of contaminants such as the heavy metal lead—is essential to public health, as chronic consumption of lead, even at low levels, can lead to myriad health issues including developmental and physical disabilities. Currently, the only reliable methods of detecting lead contaminants in water do not scale as they involve the off-site collection, preservation, and transportation of water samples to analytical chemistry laboratories, can cost upwards of hundreds of dollars, and take weeks to provide results on the safety of a single water sample. We propose to develop an inexpensive and easy-to-use device for the on-site, on- demand detection of lead in water to identify lead hazards in drinking water and ultimately reduce exposure to water contaminants.